Discovery of Selective Inhibitors for the EphA4 Kinase

Alzheimer’s is a devastating disease involving chronic, progressive neurodegenerative processes and decline
in brain cognitive function that ultimately lead to death. Accumulation of aggregates of amyloid-beta and
hyperphosphorylated tau protein in the brain causes synaptic dysfunction and loss of neurons, although the
precise mechanisms underlying the disease remain unknown. There are few drugs available to treat
Alzheimer’s disease, and they provide only limited benefits. In fact, the economic damages from Alzheimer’s
disease reach hundreds of billion dollars every year in the US alone. Many candidate drugs have been
evaluated in clinical trials in the last decade, but none has been approved. Thus, it is important to identify new
drugs based on novel targets. The EphA4 receptor tyrosine kinase has recently emerged as a novel promising
target for counteracting neurodegeneration and cognitive deficits in Alzheimer’s disease and other
neurodegenerative diseases. EphA4 receptor signaling can promote neurotoxicity when aberrantly induced by
amyloid-beta oligomers and ephrin ligands. The kinase domain of EphA4, which is responsible for the
neurotoxic effects, is a druggable target. However, small molecule kinase inhibitors targeting EphA4 with
selectivity and high affinity remain to be identified. Here we propose to perform two high-throughput screening
campaigns of EphA4. One screen will deploy Protein Thermal Shift (PTS) as the assay format and the other
screen will deploy a kinase activity assay format. The goal of these screens is to identify as broad a panel of
modulators of the kinase-dependent functions of EphA4 as possible. Use of two formats should maximize our
ability to identify a large repertoire of modulators with diverse modes of action and ultimately develop an
inhibitory compound with high selectivity for EphA4. We anticipate that the PTS screen will identify compounds
that stabilize the inactive conformation of the EphA4 intracellular region by binding not only to the kinase
domain but also to regulatory regions outside this domain. The second screen will deploy a novel in vitro
kinase assay configuration we have developed, where the inactive EphA4 intracellular region serves as the
physiological substrate for the catalytically competent EphA4 intracellular region. We anticipate that this assay
will identify not only compounds that target the EphA4 ATP binding pocket, but also allosteric inhibitors with
novel mechanisms of action. The top hits identified in the two screens and their derivatives will be
characterized and improved through rounds of secondary and tertiary biochemical and cell-based assays
already established in the laboratories of the PIs and their collaborators, complemented by structure-guided
approaches such as in silico docking and X-ray crystallography. These assays will provide formal hit validation,
selectivity profiling and initial characterization of mechanisms of action and activities in neurons. We anticipate
that this project will result in the identification of several novel EphA4 selective inhibitors that are suitable for
advancement to future studies in animal models of Alzheimer’s and other neurodegenerative diseases.

Public health relevance
Alzheimer’s disease, which becomes increasingly prevalent with age, causes the inability to function in society due to progressive loss of memory and thinking ability, ultimately leading to death. Few treatments are available, which provide only limited benefits, despite intense ongoing drug discovery efforts. Here we propose to use novel strategies that we have developed in order to find pharmacological compounds that block the function of a new promising drug target in Alzheimer’s disease, the EphA4 neuronal kinase.